Ghrelin deficiency predisposes mice to aging-associated inflammation through compromised gut function and microbiota dysbiosis

PROJECT SUMMARY A hallmark of aging is chronic, low-grade inflammation, thus coining the term “inflammaging”. Inflammaging is a highly significant risk factor for both morbidity and mortality in the elderly people. In addition, there is a growing prevalence of inflammatory bowel disease (IBD), a chronic inflammatory condition of the gastrointestinal tract, among the elderly population (>65 years of age). Increasing evidence suggest a critical role of gut microbiota dysbiosis in contributing to the inflammation in aging and in IBD. Ghrelin, a 28 a.a. peptide hormone produced mainly in the gut, plays multi-faceted roles in nutritional balance, metabolism, and inflammation. Preliminary data show aged Ghrl-/- mice (18-22 months) exhibit increased adiposity, insulin resistance, gut leakiness, and susceptibility to muscle atrophy. Remarkably, microbiome analysis reveals an increase in Firmicutes and a decrease in Bacteriodetes in the gut microbiota composition in Ghrl-/- mice at young age (6 months), prior to manifestation of age-associated metabolic dysfunction. This change in microbiota composition is reminiscent of that observed in aging C57BL/6 wildtype mice (3 versus 18 months old). Collectively, these data suggest that gut microbiota dysbiosis may be a unifying factor contributing to the susceptibility of ghrelin-deficient mice to aging-associated inflammatory pathologies. The overall objective is to determine how gut barrier function and microbiota is regulated by ghrelin under different pathological conditions. Pharmacological administration of ghrelin ameliorates sepsis-induced gut barrier dysfunction; leaky gut and microbial translocation/metabolites are factors contributing to age-associated inflammation. Hence, the central hypothesis is that ghrelin deficiency leads to decreased gut barrier function, microbiota dysbiosis and altered metabolites, predisposing the animal to inflammatory pathologies. To address this hypothesis, the following two specific aims are proposed: 1) Define the role of ghrelin in gut barrier function, microbiota and inflammation during aging; and 2) Determine the ability of ghrelin to ameliorate colitis and restore microbiota symbiosis. In Aim 1, gut permeability, microbiota composition and metabolomics, and inflammatory cytokine levels in Ghrl-/- and control WT mice at 3 and 18 months of age will be assessed. Metabolic function, colon and adipose tissue inflammation in young and old groups will be characterized, and correlated to microbial changes. In Aim 2, dextran sulfate sodium (DSS)-induced experimental model of ulcerative colitis will be used to test the efficacy and mechanism of action of ghrelin in 18 months old C57BL/6 mice. Gut function, plasma analysis and inflammation will be assessed as in Aim 1, at peak of disease activity and in remission. Fecal microbiota and metabolite will be mapped longitudinally, covering the progression of active colitis. The integrated approach combining metabolic phenotyping, inflammatory cytokine profile, gut function, microbiota and metabolomics will provide novel insights into signature bacterial populations and metabolites in the pathogenesis of aging- and colitis- associated inflammation.

Public health relevance
PROJECT NARRATIVE Public Health Relevance: Since inflammation is part of the pathogenesis to aging-associated pathologies, agents that can ameliorate gut barrier dysfunction and attenuate gut-derived inflammatory response are of significant therapeutic potential. Results from this R21 proposal will lay down the conceptual framework for a better understanding of the interactions between the gut hormone ghrelin, mucosal barrier, gut microbiota and inflammation.